Ribosomal control of muscle mass: Transcriptional and epigenetic mechanisms

PROJECT SUMMARY
Skeletal muscle plays a fundamental role in health maintenance throughout the lifespan. Loss of muscle mass
can have long-lasting deleterious consequences leading to prolonged periods of convalescence and increased
mortality. Muscle growth and maintenance are largely determined by the ability of the muscle to synthesize
proteins, which in turn is regulated by muscle ribosome. Ribosome production is partly controlled by transcription
of ribosomal (r)RNA genes (rDNA) by RNA Polymerase I, and is modulated by the transcriptional suppressors
Rb and p130. In this proposal, we seek to understand how the removal Rb and p130 leads to enhanced
transcription of rRNA genes and muscle hypertrophy. Using a novel animal model, we report exciting preliminary
results indicating that genetic removal of Rb and p130 leads to enhanced ribosome production and skeletal
muscle hypertrophy. Using this and other supporting models, we will define novel mechanisms controlling rRNA
gene expression by studying the role of transcription and chromatin remodeling factors exerting modulatory
functions on rDNA. These studies will significantly advance the field and generate novel targets for the
development of therapies to prevent the loss of muscle mass and function.

Public health relevance
PROJECT NARRATIVE This project will discover novel mechanisms controlling muscle ribosome production and hypertrophy. These data will define the molecular targets through which ribosomal production can be stimulated to promote muscle growth. The outcomes of this study provide the translational framework to prevent muscle loss and weakness associated with aging, cancer and other chronic diseases.